Cancer research education program (C-REP)

PROJECT SUMMARY
Lung cancer remains one of the most prevalent and deadly cancers in the US. Most lung cancers are not
diagnosed until after the cancer has already metastasized; stage IV patients have 5-year survival rate of only
8.2%. While in the past stage IV patients with non-small cell lung cancer (NSCLC), the most common
histology, were treated with chemotherapy, in recent years novel systemic therapies, such as targeted therapy
and immunotherapy, have been introduced and have substantially changed the landscape of late stage lung
cancer outcomes. Early-stage, surgical patients have been shown to benefit from adjuvant targeted therapy as
well. Targeted therapies work by inhibiting specific molecular pathways, the most commonly targeted of which
is the epidermal growth factor receptor (EGFR) tyrosine kinase pathway. The anaplastic lymphoma kinase
(ALK), KRAS, and BRAF pathways are other targetable oncogenic pathways. These novel therapies require
genetic testing as a basis for treatment to ensure that a druggable target is present, as not all tumors present
themselves with target mutations. About 30% of NSCLC patients will be eligible. Immunotherapies, specifically
drugs that inhibit the protein 1–programmed death ligand 1 (PD-1–PD-L1) pathway, can also substantially
improve survival in a subset of NSCLC patients, but are usually prescribed to only those patients with a high
PD-1 tumor mutational burden (TMB). Preliminary evidence suggests that utilization of novel target therapies
and immunotherapy is disproportionately different according to race/ethnicity and socioeconomic status, which
may partially explain the disparate survival outcomes in these groups of patients. More specifically, Black
NSCLC patients may be less likely to receive molecular testing compared to White patients, making them less
likely to access targeted treatments. However, no studies have yet to investigate the prevalence of oncogenic
panel testing, meaningful for both targeted or immunotherapy treatment, in a population-based dataset such as
SEER-Medicare, overall and according to race and access to quality care. To address this critical research
gap, we propose the following aims: Aim 1a) Use SEER-Medicare claims data to investigate the prevalence of
molecular tests among Black vs White advanced NSCLC patients. Aim 1b) Investigate how NSLC genetic
testing varies by urban vs rural clinical practice. We hypothesize that molecular testing is significantly less
likely to be performed among Black and rural NSCLC patients. This project will give important information on
one of the main reasons for the high mortality observed in minority and minoritized NSCLC patients, while
offering an opportunity for training in health disparities research, statistical analysis of large datasets, analysis
and interpretation of genetic data. Thus the proposed aims of this supplement complement well the scope and
mission of the original parent grant which is to expand capacity in genetics and genomic cancer research.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer mortality in the United States. Targeted therapies, such as growth factor receptor (EGFR) inhibitors, and immunotherapy have improved survival outcomes, but require genetic testing as a basis for treatment, which may not be performed equally across patients. We propose to study disparities in access to genetic testing as one of the ways to explain existing gaps in non-small cell lung cancer (NSCLC) prognosis between Black and White patients, as well as rural and urban patients.